Administrative Core

PROJECT SUMMARY (ADMINISTRATIVE CORE)
All projects and cores in the Program Project will be supported by the Administrative Core, led by Dr. Joseph
Wu. Dr. Wu will work with the Project Executive Committee and Internal and External Advisory Boards to provide
oversight and critical advice for achieving the overall project goals. Stanford Cardiovascular Institute (CVI)
Administrators Dr. Amanda Chase (Associate Director of Strategic Research Development, Stanford
Cardiovascular Institute), Mr. Stefan Pavlovic (Finance Manager, Stanford Cardiovascular Institute), and Ms.
Tongco (Project Coordinator, Stanford Cardiovascular Institute) will provide expertise in grant management,
finance management, and meeting coordination. The Administrative Core will provide monthly financial status
reports and organize regular video conferencing meetings, as well as conducting an annual in-person meeting
to include all Program Project research personnel and members of the Internal and External Advisory Boards. In
doing so, the Administrative Core will support the synergy and collaboration among the assembled group of
experts to ensure completion of the outlined goals.